Pre-transplant health coaching to improve patient-reported outcomes in lung transplant candidates

PROJECT SUMMARY/ABSTRACT
Self-management abilities reflect patients’ capacity to manage emotions, social roles, and chronic medical
conditions. In fact, self-management abilities are strongly associated with lung transplant candidates’ emotional
health. Both self-management abilities and emotional health while waiting for lung transplant predict post-
transplant quality of life. Additionally, a candidate’s self-management abilities and emotional health pre-
transplant are associated with post-transplant adherence to immunosuppressive medications. Given the
important role of these pre-transplant factors, the objective of this study is to optimize pre-transplant self-
management abilities and emotional health with the long-term objective of improving post-transplant quality of
life and transplant outcomes. Health coaching is an effective strategy to improve emotional health and self-
management abilities in other populations and in non-transplant candidates with chronic obstructive pulmonary
disease. We used semi-structured, qualitative interviews of lung transplant stakeholders to develop a relevant
health coaching intervention for adult lung transplant candidates on the waiting list. In our small, single-center
pilot trial we showed telephonic health coaching demonstrated improved pre-transplant self-management
abilities, emotional health, and quality of life in comparison to usual care. In this application, we propose a
randomized trial of a 30-minute telephonic health-coaching intervention once weekly for 12 weeks (compared to
usual care) in 230 lung transplant candidates on the waiting list at the Mayo Clinic in Florida or Minnesota or at
UW Medicine in Washington state. Patient-reported outcome instruments measuring emotional health, self-
management, and quality of life will be measured at baseline, 12-16 weeks following enrollment, and post-
transplant. Our primary outcomes will be differences between groups in Chronic Respiratory Questionnaire
(CRQ) domains of Mastery (a measure of self-management) and Emotional function adjusted for baseline
values. Secondary outcomes will compare the differences between groups of other psychometric questionnaire
scores, adjusted for baseline, as well as short-term post-transplant outcomes. The long-term goal of this
application is to optimize post-transplant outcomes through effective pre-transplant interventions. Our central
hypothesis is that health coaching will improve lung transplant patients’ self-management abilities, emotional
health, and quality of life pre-transplant. We further hypothesize that future studies will demonstrate that these
pre-transplant improvements in self-management abilities and emotional health will translate into improved post-
transplant quality of life. The results of this study will be used to refine the intervention and plan for a larger,
multi-center trial designed to optimize dissemination and implementation in diverse settings. This proposal
supports the NIH mission by striving to improve outcomes in lung disease patients while supporting a new
investigator in her to transition to research independence.

Public health relevance
PROJECT NARRATIVE Patients with lung disease who have better self-management abilities or emotional health have an improved quality of life following lung transplant surgery. Health and wellness coaching is known to improve patients’ self- management abilities and emotional health in certain diseases, such as chronic obstructive lung disease (a.k.a. emphysema). In this application, we will investigate whether a weekly health and wellness coaching intervention by telephone improves pre-transplant self-management abilities and emotional health in patients on the lung transplant waiting list and whether it also improves patients’ quality of life.